Is the gut important in multiple joint osteoarthritis? A multimodal investigation in humans and pet dogs

PROJECT SUMMARY
The parent project (Is the gut important in multiple joint osteoarthritis? A multimodal investigation in humans
and pet dogs, R01AR080733) integrates serum biomarkers and radiographic measures of the burden of the
disease of OA with measures of intestinal permeability and microbiome assessments in both humans and
dogs. It will significantly advance our understanding of the role of a hitherto ignored driving etiology in MJOA –
altered intestinal permeability – and create a novel transspecies model platform for testing therapeutics. This
proposed supplement effectively synergizes with the parent project by adding a focus on a clinically
critical dimension – pain associated with multi-joint osteoarthritis (MJOA). Pain associated with OA is
what patients care about. This supplement will generate data that will help us better understand the multiple
factors that drive pain and uncover novel therapeutic opportunities. We will expand and enhance our existing
innovative work to include novel biomarkers of pain and pain assays relevant to the pain experience in
humans and in dogs. There are two core features of this integration and enhancement: 1) to extend the
analysis of samples in already being collected to include promising serum biomarkers for musculoskeletal pain
and enhance pain phenotyping in the human cohort; 2) to apply advanced analytical techniques to the entire
data set (parent and supplemental data) allowing us to perform elegant and innovative pain phenotyping in
relation to intestinal permeability, gut microbiome and burden of OA. To advance our understanding of
musculoskeletal pain, we will use cutting-edge machine learning analytical approaches to understand how pain
phenotype(s), microbiome enterotype(s) and biomarker endotype(s) vary together and individually to advance
our understanding of the complex multi-modal and multi-dimensional pain experience of OA patients. This
supplement proposal is not a stand-alone project, rather it enriches the parent project and expands the
opportunities for discovery of potential pain therapeutic strategies. The combined expertise of the two PIs and
teams (OA, musculoskeletal pain, application of machine learning) makes us ideally suited to perform the
proposed work. Integrating the supplement work at this stage is fiscally efficient, and scientifically it will
accelerate the generation of data to support new investigative strategies that will lead to a better
understanding of how to mitigate musculoskeletal pain.

Public health relevance
Project Narrative Osteoarthritis (OA), which often occurs in multiple joints (MJOA), is a leading cause of chronic pain; current drug treatments for pain are associated with substantial side effects in that ~17,000 individuals die each year from NSAID-associated side effects, and opioid overdose contributes to ~50,000 deaths annually. Our parent project integrates serum biomarkers and radiographic measures of the burden of the disease of OA with measures of intestinal permeability and microbiome assessments in both humans and dogs to advance our understanding of role of the ‘leaky gut’ in MJOA. This supplement proposal seeks to enhance this rich data set with additional biomarkers and measures specific to pain and applies advanced (machine learning) analytical techniques to perform elegant and innovative pain phenotyping in relation to intestinal permeability, gut microbiome, and burden of OA, to identify novel therapeutic opportunities to alleviate pain.